Synergistic Interaction of FTD Genes in Neuroinflammation and Neurodegeneration

Project Summary
Frontotemporal dementia (FTD) is an early onset neurodegenerative disease, and the second most common
cause of dementia in patients 60 years or younger. The majority of familial FTD are caused by intronic
hexanucleotide (CCCCGG) repeat expansion in chromosome 9 open reading frame 72 (C9orf72) gene and by
dominant mutations in the Progranulin (GRN) gene, causing haploinsufficiency in both genes, abnormal protein
aggregate formation in neurons. Several functional and transcriptomic studies have shown that mice with null
mutation in C9orf72 or Grn show abnormal microglia (resident CNS immune cells) activation mediated
pathogenesis of neurodegeneration in FTD. While the exact functions for C9orf72 and Progranulin (PGRN
[protein]) are still unclear, several studies have implicated both in autophagy and endolysosomal pathways in
neurons and microglia, and concurrent mutations resulting in increased brain atrophy in patients. These results
suggest a possible interaction between C9orf72 and PGRN in neurodegeneration during brain aging
The goal of my project is to investigate the synergistic interaction of C9orf72 and Grn genes in glial homeostasis
and neuronal degeneration using mouse models. In support of this, my preliminary data showed that C9orf72-/-
;Grn-/- DKO mice have significantly shortened lifespan, much shorter than C9orf72-/- mice, Grn-/- mice and control
mice. Brain pathology examination in C9orf72-/-;Grn-/- DKO mice showed age-dependent gliosis as well as
neuronal TDP-43 aggregates that are more pronounced and wide-spread than those in C9orf72-/- or Grn-/- mice.
These results support my hypothesis and further indicate that loss of C9orf72 and Grn synergistically disrupt
glia-neuron homeostasis and lead to more pronounced neurodegeneration phenotype. For the F00 phase,
I propose to uncover the mechanism of C9 and PGRN in neurodegeneration in the aging brain via single-cell
and bulk RNA-sequencing in 7 and 12 months old control, C9orf72-/-, Grn-/- and C9orf72-/-;Grn-/- DKO brain to
determine how loss of these two FTD genes disrupts the homeostasis in glia-neuron interaction (Aim 2a). These
transcriptomic data will be validated using in situ hybridization, immunohistochemistry and western blots (Aim
2b). Finally, I propose to develop in vitro cultures, including neuron-only cultures and glia-neuron co-cultures,
which will provide more insights into the synergistic interaction between C9orf72 and PGRN in the autophagy-
lysosome pathways and in glia-mediated toxicity to neurons (Aim 2c).
For the K00 phase of this fellowship, I plan to develop induced pluripotent stem cells (IPSC)-derived 3D brain
organoids as model systems to investigate disease mechanism and identify therapeutics for neurodegeneration.
To identify signaling pathways that could be affected by diseases, I plan on using single-cell transcriptomics on
patient IPSC derived glia-neuron organoids, followed by CRISPR/Cas9-based manipulation strategies on the
signaling pathways dysregulated in these brain organoids to elucidate the diseases progression mechanisms.

Public health relevance
Project Narrative This proposal investigates the overarching hypothesis that C9orf72 and Progranulin cooperatively regulate autophagy and endolysosomal pathways in neurons and microglia. During the F99 phase, I propose to perform transcriptomics, biochemistry and cell biology approaches to uncover the mechanism of the interaction between C9orf72 and Progranulin in the autophagy-endolysosomal pathway. Results from these studies will provide a strong foundation for my future study to combine CRISPR/Cas9 technology and 3D brain organoid model for neurodegeneration during the K00 phase of this proposal.